Symposium on the Immune System of Bacteria

Project Summary – Symposium on the Immune System of Bacteria
The conference organizers are requesting support for convening the 2024 Symposium on the Immune System
of Bacteria. An explosion in discoveries explaining how bacterial cells defend against bacteriophage infection
has revolutionized the fields of immunology and microbiology and revealed a direct connection between bacterial
anti-phage defense and the mechanisms that control human antiviral immunity. The planned 2024 Symposium
on the Immune System of Bacteria will be the first to gather the forming international community in the US, and
will be crucial for establishing priority research directions in the field and training the next generation of young
US scientists in a rapidly emerging topic in contemporary microbiology. The topic of the planned symposium
perfectly aligns with NIAID's emphasis on fundamental microbiology, virology, and immunology research into the
mechanisms that control infectious diseases. The conference will convene a diverse panel of 19 invited speakers
that will present along with 15 early-career science speakers selected from submitted abstracts. Additionally, the
conference will have two poster sessions to highlight emerging research from PhD student and science trainees.
The 2024 Symposium on the Immune System of Bacteria will provide a unique opportunity to create a diverse
and inclusive environment and increase representation in the field. A particular emphasis of the conference is
highlighting the next generation of scientists in the field including early career stage scientists and new
investigators to bacterial immunity. Specific initiatives of the conference include a data presentation and live
survey session dedicated to addressing inclusivity in the community, and creation of mentor-mentee pairs to
enhance training and accessibility of senior scientists. Taking place in Boston, MA, the conference will ensure
accessibility to individuals with disabilities and to all members of the community that may be traveling with family.
Specific Aims of the conference include the following:
1) Bring together the community of researchers studying phage defense and antiviral immunity
2) Exchange unpublished data and establish priority questions in research of host-virus interactions
3) Provide an inclusive environment to foster the next generation of scientists

Public health relevance
Project Narrative – Symposium on the Immune System of Bacteria Defining at the mechanistic level how cells resist viral infection is essential to controlling and treating infectious diseases. The proposed 2024 Symposium on the Immune System of Bacteria will convene US and international scientists in the emerging field of bacterial anti-phage defense and the evolutionary connection between the immune system of bacteria and human antiviral immunity. The conference will establish priority directions for future research and create a unique opportunity to foster inclusivity and the next generation of researchers studying microbiology, virology, and immunology.